iPRISM (Imaging-enhanced Prediction of RIsk for Sudden cardiac death in hcM)

Project Summary
Hypertrophic cardiomyopathy (HCM) is an inherited heart condition where the heart is thicker than normal. It is
an inheritable genetic condition and the most common cause of sudden collapse and death (SCD) in children.
SCD can be prevented by placing an internal defibrillator (ICD) which can stop life-threatening arrhythmias by
delivering an electrical shock to the heart. However, ICD placement involves surgery, can cause multiple
problems and is expensive. Therefore, we need to make sure we place ICDs only in those who are likely to need
them while avoiding them in those who do not. For that decision it is important to understand a patient's risk for
SCD. Current methods to assess risk of SCD in HCM are inaccurate. They use elements from the patient's
history and tests such as the echocardiogram and electrocardiogram. Work on adults and some studies in
children) suggest that findings on genetic testing and scars in the heart muscle detected by magnetic resonance
imaging (MRI) scanning are also markers of SCD risk. In this study we will examine the gene test findings and
heart MRI scans of children and adolescents with HCM in greater detail. Careful study of the scars, including
their presence, extent, and appearance, will help us develop a better understanding of who is at risk for SCD.
We will combine this information and other risk factors to develop a new tool to better know the likelihood of
SCD. We will then tests how well this tool works in a separate group of children with HCM. In addition to analyzing
the images by an experienced MRI physician, we will use artificial intelligence to extract additional information
from the images and explore whether any of it can improve the prediction of SCD. We expect that our study will
improve our ability to predict SCD and save lives of children with HCM.

Public health relevance
Project Narrative Hypertrophic cardiomyopathy (HCM) is a frequent cause of sudden cardiac death (SCD) due to lethal arrhythmias and, although SCD can be prevented by using an implanted defibrillator (ICD), this comes with the risk of side effects, especially in children and adolescents. Accurate prediction of who is at risk is needed to accurately identify children who need an ICD so that unnecessary morbidity from an ICD can also be avoided. We believe that information from gene testing and scars within the heart derived from a cardiac magnetic resonance imaging scan can significantly improve our ability to predict the risk of SCD in children with HCM, thereby helping to save lives while minimizing the unwanted effects of ICDs.